Biostatistics, Epidemiology, and Research Design Core

Effective clinical and translational research (CTR) requires rigorous study designs, appropriate application of
analytic methods, and careful reporting. The Biostatistics, Epidemiology, and Research Design (BERD) has
been instrumental in expanding clinical and translational research with new investigators, community partners,
and programs of the OSCTR supporting more than 1000 research projects since the OSCTR was established.
The BERD has enhanced research methods training, expanded the use of novel analytic methods and
research, and helped build research infrastructure through clinical informatics support, enhancement of
REDCap infrastructure, and growth of the survey center established by the OSCTR. The mission of the BERD
Core is to enable OSCTR investigators and partner institutions to design, perform, and report rigorous,
reproducible, and innovative studies that can be applied to improve clinical care and patient well-being in
Oklahoma and other IDeA states. To do this, the BERD Core will provide consultative expertise in biostatistics,
epidemiology, qualitative research, and survey design methods; deliver methodologic training, analytic tools,
and learning resources; and develop and apply novel research designs and analytic methods focused on the
needs of OSCTR researchers. BERD Core members will continue to collaborate with investigators through the
spectrum of basic medical science laboratory research, preclinical studies, randomized controlled clinical trials,
translational studies, dissemination and implementation studies, and community-based studies. It will help
investigators address sources of bias, identify sufficient sample sizes, select measurement instruments,
perform data quality control, manage and analyze data, and report study results. A new BERD initiative will
establish the Design and Computational Resources Unit to provide training tools and resources in
epidemiologic research design and analysis of health data. The multimedia and computational tools will cover
a range of introductory to advanced topics in research design and biostatistical analyses and be made
available on the Gateway to Research in Oklahoma portal. Finally, to advance biostatistics and epidemiologic
methods, the BERD Core will hold monthly seminars to disseminate novel research designs, analysis methods,
and research findings and perform methodological research to adapt existing methods or develop new
approaches to address research questions – for example, by developing new statistical methods to reduce
bias and increase estimation efficiency in small populations, such as American Indian tribes. Together, these
BERD Core activities enable OSCTR investigators to perform rigorous, reproducible, and innovative research
to better understand and address health needs in Oklahoma.